GONOCOCCAL PILI--STUDIES OF STRUCTURE AND FUNCTION

Our laboratory studies the molecular biology of infection caused by Neisseria gonorrheae with an emphasis on investigations directed at understanding the structure and function of bacterial surface proteins.